Administrative Core

The overall goal of the Southern California Center for Chronic Health Disparities in Latino Families
and Children (SCC-CHDLFC) is to establish a regional coalition of academic, clinical, government and
community stakeholders to address the co-occurring disparities in obesity, type 2 diabetes, non-alcoholic fatty
liver disease, and dyslipidemia that are disproportionally affecting Latinos in our region with a focus on
addressing early life determinants and family-based strategies for prevention and treatment. The SCC-CHDLFC
is a comprehensive and inclusive regional coalition of individuals and organizations that builds on existing
collaborations and leverages numerous resources. This coalition will provide the necessary expertise and
support to advance understanding, prevention, and treatment of the multilevel behavioral, nutritional, biological,
inter-personal, social, and environmental factors that contribute to vulnerabilities for these chronic conditions
among Latinos. The overall goal of the Administrative Core is to ensure the success, scientific rigor, and regional
and societal impact of the Center. The Core will be led by Drs. Goran (CHLA) and Baezconde-Garbanati (USC)
who provide complementary expertise in clinical/translational research in Latinos and community engagement
and have a track record of working together leading mulit-investigator Centers related to minority health and
health disparities. The Core will be responsible for structuring, initiating, maintaining, and coordinating all Center
activities to ensure that goals are met, including scientific progress, developing a diverse pool of young
investigators, program evaluation, and influencing lasting changes at the community and system levels, through
3 Specific Aims. Aim 1 is to provide overall leadership and vision as well as scientific, fiscal, and administrative
oversight. This oversight will ensure scientific rigor and maximize interaction between Center cores, research
projects, and pilot studies to ensure integrated efforts in research, training, career development, and community
engagement are met, that team science strategies are utilized, and that trans-disciplinary opportunities are
maximized. Aim 2 is to ensure data quality and harmonization by providing high-level methodological expertise
to the projects and pilot studies through a Methods and Data Sub-Core. By leveraging existing Research Cores,
we will provide efficient and rigorous Center-wide expertise in biostatistics, data management and and
assessment of social determinants of health, dietary intake, and geospatial factors. This will accelerate and
promote transdisciplinary research, integration, and synergy across our Center and the P50 program. Aim 3 is
to conduct ongoing program evaluation to guide the progress and impact of the Center, with a feedback loop for
Center improvements to ensure the Center stays on track and meets its objectives. Ongoing and systematic
evaluation will determine progress towards aims within each project and core, and achievement of milestones
and benchmarks of the projects, cores, and pilot studies, as well as evaluating the effectiveness of interaction
between Center components, investigator development, and meeting outreach and engagement objectives.